PET Enabled Y-90 Microspheres for Radioembolization of Liver Tumors

Project Summary/Abstract
Current radioembolic Y-90 microspheres have been generally recognized as the state-of-the-art for treating
primary and metastatic liver tumors. However, the clinical results vary vastly due to the lack of accurate
diagnostic imaging for dose and treatment planning and the lack of image guidance and dose conformation
during the administration of Y-90 microspheres. The investigation team has established the feasibility of
using PET imaging agent alone or along with Y-90. All key feasibilities have been demonstrated as
proposed in Phases I & II. This proposed Phase IIB research focuses on the preparation of radioembolic Y-
90 microspheres at therapeutic levels of Y-90 with enhanced personnel safety, and the research also focuses
on the calibration of Y-90 dose distribution that is critical and practical for real-time Y-90 dosimetry to
improve much desired efficacy. The objectives of this proposed Phase IIB research are (1) to establish a
microfabrication process for on-demand production of PET emitting microspheres using commercially viable
glass compositions, (2) to reliably produce low-cost Y-90 radioisotope, (3) to assess biocompatibility and
biological risks to gain FDA acceptance for a human clinical investigation, and (4) to demonstrate clinical
utility of PET emitting glass microspheres. Successful completion of the proposed Phase IIB research will
lead to PET-enabled Y-90 glass microspheres to improve patient safety and to advance Y-90
radioembolization from palliative treatment to curative treatment for liver cancer, especially primary liver
cancer. In addition, this Phase IIB advanced development has the potential to drastically reduce the cost of
Y-90 radioembolization agents so that this treatment option is more affordable in addition to being more
effective.

Public health relevance
Project Narrative A successful real-time quantitative dosimetry assessment has the potential to dramatically improve the efficacy of Y-90 radioembolization for the treatment of primary and metastatic tumors. It is now technologically feasible to have optimal patient dose planning and intraoperative dose escalation to the tumors without the risk of overdosing the healthy tissue or organs. Unexpected shunting of Y-90 radioembolic microspheres and, more importantly, over-embolization with reflux of the Y-90 microspheres into gastrointestinal arteries can be detected early, and corrective actions can be taken intraoperatively during the administration of the Y-90 radioembolic microspheres. The proposed imaging-only embolic microsphere also has the potential to become an ideal dose-planning device for current Y-90 radioembolic microspheres (Therasphere® or SIR-Spheres®) so that a much broader applicability of this development can be achieved for the maximum benefits to liver cancer patients. The low cost of this imaging-enabled Y-90 microsphere is most significant in making this effective radioembolization device more affordable to patients in USA and in developing regions of the world.